ICC 1293 PHASE II STUDY OF TOPOTECAN IN PTS WITH ADVANCED COLORECTAL CARCINOMA

To determine response rate and duration of response in patients with untreated recurrent or metastatic adenocarcinoma of the colon or rectum; to describe associated toxicities; determine pharmacokinetic parameters and to determine topoisomerase I enzyme levels obtained from metastatic lesions and correlate with clinical response.